Vascular Leak and Outcomes in IPF

Idiopathic pulmonary fibrosis (IPF) is a progressive and ultimately fatal disease. Within IPF, however, there
exists marked disease heterogeneity as some patients experience a rapidly progressive course while others
experience prolonged periods of stability or stepwise declines triggered by disease exacerbations.
Unfortunately, there are no accepted means by which patients can be clinically “phenotyped” into these
different disease courses at the time of diagnosis. The ability to predict an individual patient’s pace of
progression would greatly impact patient care by enabling better prognostication, individualization of treatment
plans, and early evaluation for lung transplantation for those at highest risk of rapidly progressive disease.
Such knowledge could also be utilized as a cohort enrichment strategy allowing new IPF therapies to be
evaluated in patients at greatest risk of progression thus improving clinical trial feasibility. We hypothesize that
disease activity in IPF is driven by ongoing lung injury and that measurements of ongoing lung injury could be
utilized to predict prognosis and treatment response. Vascular leak, a cardinal response to tissue injury, has
been implicated in the development of IPF. Alveolar-capillary permeability is increased in the lungs of IPF
patients, and the extent of this increase has been shown to correlate with disease progression and mortality.
We will use the advanced magnetic resonance imaging (MRI) technique of dynamic contrast-enhanced (DCE)
MRI to assess vascular permeability in the lungs of IPF patients and healthy volunteers and prospectively
evaluate if these MRI-derived measures of lung vascular permeability predict subsequent IPF disease
progression. We will also evaluate whether increased plasma levels of soluble Ephrin-B2 (sEphrin-B2), a novel
molecular biomarker of lung injury in fibrosis, can identify IPF patients most likely to experience disease
progression. Lastly, we will perform lung DCE-MRI prior to and after initiation of anti-fibrotic therapy with
nintedanib, which we hypothesize will decrease lung vascular permeability by inhibiting vascular endothelial
growth factor (VEGF), to assess whether our MRI-derived lung vascular permeability measures are decreased
with treatment. This research will be performed by Dr. Sydney Montesi, a pulmonary and critical care physician
at Massachusetts General Hospital, an Instructor of Medicine at Harvard Medical School, and a specialist in
the care of patients with pulmonary fibrosis. She will receive first-rate training in advanced lung imaging and
biomarker development. She will be exceptionally mentored by Dr. Peter Caravan, a pioneer in molecular
imaging of fibrosis, and co-mentored by Dr. David Christiani, an expert in biomarker development for lung
injury. She will perform her research in a world-renowned academic center with all required resources available
to her. Dr. Montesi’s goal is to become a physician-scientist in patient-oriented research of pulmonary fibrosis.
This K23 award will provide her with the training and mentorship to achieve independence and apply for her
first R01.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a progressive and often fatal disease with marked individual disease heterogeneity as some patients progress rapidly while others have a disease course marked by periods of relative stability. The ability to distinguish what patients are most likely to progress quickly represents an urgent and unmet need for both IPF patient care and research. The purpose of this study is to use novel imaging techniques and molecular biomarkers of lung injury to assess IPF disease activity with the ultimate goal of developing the ability to predict disease progression.